Investigating the neurophysiological basis of circuit-specific laminar rs-fMRI

Resting-state fMRI has emerged as a potential method to identify diagnostic bio-imaging markers of a broad
spectrum of neurological disorders by measuring the low-frequency fluctuation (LFF) correlation features of
diseased brains. Due to the fMRI signal's indirect coupling to neuronal activity, a fundamental challenge of rsfMRI
mapping is how to extract the true "functional connectivity" feature across cortices with circuit specificity.
Both direct corticocortical connections, e.g. callosal projections, and subcortical neuromodulatory projections
can modulate rs-fMRI connectivity with converging effects on neuro-glio-vascular (NGV) interactions. Also, autonomic
regulation on gliovascular dynamics further confounds rs-fMRI LFF when interpreting the brain damage
with vascular impairment in various cerebrovascular diseases. We propose to implement line-scanning
and single-vessel fMRI methods in a multi-modal platform to dissect laminar and vascular-specific rs-fMRI LFF
and decipher NGV signaling underlying rs-fMRI LFF. Here, we will focus on elucidating the transcallosal circuitbased
interhemispheric rs-fMRI LFF correlation in the normal and diseased mouse model with hypoperfusioninduced
cerebrovascular white matter injury in the corpus callosum. Three aims will be addressed: 1 ). We will
investigate the causal linkage between laminar-specific bilateral LFF and transcallosal projection. Two hypotheses
will be tested: i). Layer-specific transcallosal projections determine bilateral LFF laminar correlation patterns,
and ii). Callosal-driven laminar LFF holds distinct oscillation features from brain state-dependent global
LFF. 2). We will differentiate the NGV signaling of callosal-specific and global vascular LFF using multi-modal
fMRI. Also, we will test two hypotheses: i). Callosal projection neuron-specific oscillation mediates circuit-specific
bilateral LFF, and ii). Distinct astrocytic Ca2+ signals coupled to either callosal projection neuronal activity
or global neuromodulation contribute to different forms of LFF correlation. 3). We will specify callosal-specific
and global vascular LFF in the hypoperfusion-induced white matter injury mouse model. We will test if hypoperfusion-
induced cerebral flow changes alter global vascular LFF and hypoperfusion-induced injury in the
corpus callosum leads to altered bilateral rs-fMRI connectivity. This proposal aims to reveal the mechanistic
NGV regulation of circuit-specific rs-fMRI LFF and apply novel rs-fMRI methods in the diseased mouse model
to set the foundation to translate specific LFF correlation patterns as potential biomarkers of circuit dysfunction
or vascular impairment in pathological brains.

Public health relevance
An ongoing challenge of functional connectivity mapping with resting-state (rs) fMRI is to elucidate the circuitspecific versus global vascular correlation. Animal fMRI has played a critical role in mapping brain function with multi-modal neuro-techniques across different spatial scales. This proposal aims to apply novel rs-fMRI methods to specify circuit-specific rs-fMRI signals and examine circuit dysfunction in a mouse model with cerebrovascular white matter injury. We expect to improve the mechanistic understanding of circuit-specific rs-fMRI connectivity and to specify altered rs-fMRI signals as biomarkers of pathological circuit function or cerebrovascular impairments.